Hox-Regulated MSCs in Skeletal Development, Growth and Fracture Healing

PROJECT SUMMARY/ABSTRACT
Although the critical roles Hox genes play in establishing skeletal morphology has been known for
decades, virtually nothing is understood regarding the molecular mechanisms by which Hox genes function in
the skeleton. Utilizing a unique collection of genetic tools that permit live visualization of Hox expression
(Hoxa11eGFP), Cre-mediated lineage labeling and/or conditional deletion (HoxCreERT2, Hoxd11LoxP/LoxP) and
assessment of Hox11 chromatin binding sites (unpublished, validated Hoxa113XFLAG and Hoxd113XFLAG alleles),
the overall objective of this application is to dissect the pathways and targets regulated by Hox transcription
factors in skeletal stem/progenitor cells to regulate osteogenic and chondrogenesis differentiation. Previous
work has demonstrated that Hox-expressing stem/progenitors are maintained in the skeleton in the absence of
Hox function, and osteo- and chondrogenic lineages continue to emerge (Sox9-, Osx-/Runx2-expressing), but
differentiation is incomplete. Osteoblasts do not progress to mature stages, and chondrocytes fail to undergo
normal apoptosis and replacement by bony matrix in Hox mutants. This differentiation defect can be
recapitulated in vitro. Based on previously published work and preliminary data, the central hypothesis is that
Hox transcription factors regulate critical downstream events at the top of the hierarchy during
osteochondrogenic differentiation from skeletal stem/progenitor cells in parallel with canonical differentiation
factors. This project will utilize the Hoxa11eGFP reporter and Hoxa11CreERT2-mediated lineage labeling in the
presence and absence of adult conditional deletion of Hoxd11 to probe the single cell trajectories of Hox11-
expressing progenitors as they expand and differentiate into cartilage and bone in response to injury (Aim 1).
The recapitulation of osteo- and chondrogenic differentiation defects in Hox11 mutants in vitro permits a
comparative assessment of differential gene expression during temporally controlled differentiation (Aim 2).
Newly generated and validated Hoxa113XFLAG; Hoxd113XFLAG epitope-tagged alleles will be utilized to interrogate
the sites of chromatin binding in Hox-expressing progenitors and early differentiating cells (Aim 3). The
research proposal is innovative in its use of sophisticated genetic tools generated by the research team, the
combined in vivo and in vitro approaches, and critical inclusion of a co-investigator and her team with
biostatistics expertise. The proposed research is significant as it addresses the longstanding and highly
significant question of the molecular mechanism of Hox function in the skeleton. As Hox expression is only
observed in skeletal stem/progenitors and early differentiation markers initiate as cells exit the Hox lineage,
dissecting the downstream targets and pathways regulated by Hox that are critical to complete successful
osteogenic and chondrogenic differentiation will provide impactful new knowledge of skeletal biology.

Public health relevance
NARRATIVE The proposed research is focused on understanding the mechanism of Hox function in regulating skeletal differentiation. Loss of Hox function impacts the ability of skeletal stem/progenitors to complete differentiation down the osteogenic and chondrogenic lineages via unknown pathways. The conserved, region-specific, expression of Hox genes in the skeletal stem/progenitors (MSCs) in all vertebrates, including humans, supports the significance and relevance of these studies and fulfills the mission and goal of the NIH to understand the processes of human growth and development.